Therapeutic targeting mesenchymal transition in newly diagnosed and recurrent GBM

PROJECT SUMMARY
IDHwt glioblastoma (GBM) patients still live an average of ~15-months, despite advances in multimodal
therapy. A central issue confounding treatment is the heterogeneous nature of this aggressive tumor.
Transcriptomics has defined three GBM molecular subtypes - proneural (PN), classical (CL), and mesenchymal
(MES).7 Individual tumors typically harbor mixtures of all three subtypes in spatially distinct subpopulations with
different mutation profiles, making mutation- or pathway-specific therapies less effective. While cell-intrinsic
mechanisms of therapeutic resistance have garnered considerable scientific attention, much less is known about
cellular interactions in the tumor microenvironment that contribute to therapeutic recalcitrance. A hallmark
mutation in 60% of GBM is amplification and mutation of the epidermal growth factor receptor (EGFR). The most
common EGFR alteration, EGFRvIII, results from deletion within its extracellular domain, yielding a constitutively
active receptor that conveys tumor-enhancing and therapy-resisting functions.8 Genetic and pharmacological
data from our lab show that EGFRvIII activity, specifically in the context of PI3K pathway activation, results in
nuclear localization of the NF-kB subunit RelA (p65), its association with members of the BET (bromodomain
and extra terminal domain) family of acetylated lysine-binding proteins, and transcriptional activation of
inflammatory genes.6,9 The requirement of RelA acetylation at lysine 310 (acK310-RelA) for BET bromodomain
interactions10 and the central role of NF-kB in driving a PN/CL to MES phenotype transition (collectively MES
transition – MESt),6,11 immune evasion,3 and therapy resistance12 leads us to postulate that the acK310-
RelA:BET protein complex is a druggable regulatory switch mediating MESt and treatment resistance.
The goal of this project is to dissect and target mechanisms whereby tumors undergo MESt and acquire
therapeutic resistance through the acK310-RelA:BET switch. We have identified a druggable node of specific
bromodomains, through precise drug targeting, that controls the pro-inflammatory activity of the acK310-
RelA:BET complex.6 The following lines of experimentation will be employed in the newly diagnosed and
recurrent GBM settings. SA1 will use genetic and pharmacological approaches to determine upstream effector
mechanisms mediating RelA K310 acetylation and associated MESt, including abundance of tumor-associated
microglia and macrophages (TAM), and resistance to standard-of-care (SOC) therapy. SA2 will functionally
analyze BET family members BRD2-4 through gene knockout, gene editing, inducible protein degradation,
selective bromodomain (BD1, BD2) drug targeting, and assessment of acK310-RelA:BET induced transcription
programs and associated epigenomic rewiring. SA3 will specifically focus on the recurrent GBM setting, where
we will investigate direct drug targeting of the acK310-RelA:BET interaction to mitigate resistance to salvage
radiation and promote phagocytotic recognition by TAM. These studies will be central to identifying a
therapeutically tractable node promoting MESt and nominate a specific drug for further development.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM), the most common primary brain tumor in adults, is a highly invasive, neurologically destructive tumor with a survival range of 12-15 months despite maximum treatment efforts. A central issue contributing to treatment failure is the heterogeneous or varied cell type composition of these tumors. This proposal will identify mechanisms that promote a mesenchymal tumor state, synonymous with therapy resistance. We will pharmacologically target this state to improve therapeutic efficacy of known agents for patients with newly diagnosed and recurrent GBM.